Multiscale Biophotonics: A Platform for Interdisciplinary Biomedical Research Training and Career Development

PROJECT SUMMARY
The overarching objectives and specific aims of this IPERT program are to (1) prepare trainees for
successful multi-disciplinary Biophotonics careers and support biomedical workforce development. This will
be achieved by (2) advancing the technical and operational proficiency of our trainees in Multiscale
Biophotonics through an integration of modeling, computation, experiment, and problem-based learning, and
(3) providing our trainees with sustained mentorship for professional development. This will be accomplished
by establishing foundational technical and operational skills in the area of Multiscale Biophotonics during a
12-day onsite short course at the University of California, Irvine. This 12-day short course utilizes an
integrated modular design and evidence based learning consisting of (a) lectures, (b) technology
demonstrations, (c) laboratories combining hands-on data acquisition with computational analysis using our
custom Virtual Tissue Simulator (VTS) software platform, (d) Team Science training, (e) mentored capstone
problem-based learning (PBL) proposal development, (f) guest lectures on the use of an interdisciplinary
Biophotonics approach to address biomedical problems, (g) panel discussions on academic and industrial
career paths, and (h) tours of academic and industrial facilities. Further application and growth in trainee skill
development will be accomplished by a mentored capstone problem-based learning project to be pursued for
one year following the short course completion. In parallel with the short course and year-long PBL project,
we will offer both technical and professional mentorship. Our technical mentorship aims to support
Biophotonics, instrument and measurement design, technology development, as well as modeling,
computation and usage of open-source Computational Biophotonics Tools. Our professional mentorship
program aims to aid trainees in identifying appropriate short- and long-term professional goals and develop
strategies to attain them. The course has been designed for interdisciplinary group of graduate student, post-
doctoral researcher, and faculty scientists and engineers. We propose an aggressive outreach plan to support
the participation of trainees who are traditionally underrepresented within STEM as well as from geographic
regions that have historically received low levels of NIH support. We aim to train up to 20 individuals each
year.
In summary, our program provides a technical foundation and mentoring support for trainees to advance
and apply an integrated technical proficiency in Multiscale Biophotonics to solve biomedical challenges. As
the integration of expertise spanning modeling, computation and experiment are in demand in biomedical
research and technology development, the proposed program advances NIGMS programmatic goals for
training a diverse biomedical research workforce with expertise most relevant to the NIGMS Division of
Biophysics, Biomedical Technology, and Computational Biosciences.

Public health relevance
PROJECT NARRATIVE The application of modeling, computation, and experimental approaches for technology development is in high demand in both industry and academic Biophotonics research and development with an estimated economic impact of $90 billion annually. Our proposed program is designed principally for graduate student, post-doctoral, and early-career faculty researchers eager to advance their technical proficiency in Multiscale Biophotonics and access mentoring support for professional development to establish a successful career in support of the Biomedical workforce. The combination of our onsite 12-day intensive short course in combination with a subsequent year-long capstone problem-based learning module and sustained technical and professional mentorship collectively provides an evidence-based approach by which trainees will acquire both technical proficiency and confidence to pursue a successful biomedical careers in this important area.